Role of physiological patterns in hippocampal-prefrontal interactions

Project Summary/ Abstract
The hippocampus and medial prefrontal cortex (PFC) are both critical for learning and memory-guided behavior.
Coordination of neural activity between these regions is necessary for memory and cognitive processes,
however, the nature of these interactions and their roles are still unclear. We have established multiple timescale
neural representations in these regions for spatial learning and memory-guided behavior, with inter-regional
coordination during spatial firing and theta oscillations in exploratory behavior, and during sharp-wave ripple
(SWR) associated replay in sleep and awake immobility periods. Here, we will investigate the roles of these
physiological network patterns in learning and memory-guided navigation by combining behavioral methods in
rats, high-density recordings, and causal manipulation methods. (Aim 1) The influence of reward on mnemonic
representations is key to understanding the role of hippocampal-prefrontal activity patterns in memory-guided
behavior. In particular, it is known that reward changes influence hippocampal replay, and replay is thought to
play a role in linking actions to reward for reinforcement learning. To address this question directly, we have
developed methods in TH-Cre rats for optogenetic tagging and identification of dopaminergic ventral tegmental
area (VTA) neurons which encode reward prediction error, simultaneously with recordings from hippocampal
and prefrontal ensembles. We will record and manipulate VTA dopamine neuron firing to examine the influence
on replay and task representations in the hippocampal-prefrontal network during learning of new spatial rules.
(Aim 2) The hippocampus and prefrontal cortex are both known to be important for contextual encoding and
generalizing experiences across contexts, but the mechanisms are unclear. Our preliminary data show rule-
selective encoding by prefrontal neurons that is maintained across spatial contexts, whereas hippocampal CA1
neurons remap across contexts. Further, we have also found coordinated hippocampal-prefrontal ripples vs
independent cortical ripples with distinct reactivation patterns. We will examine whether hippocampal-prefrontal
ensembles underlie rule representations and contextual encoding, whether theta sequences maintain encoding
of current context, and test the hypothesis that replay during coordinated ripples enables associations across
contexts. (Aim 3) Goal representations are considered central to navigation, but the mechanisms for goal coding
and hippocampal-prefrontal representations for memory-guided navigation are still unclear. Our preliminary data
using a complex 2-d maze with flexible goal locations and barriers supports goal representations and replay by
hippocampal and prefrontal ensembles during navigation. We will test the hypotheses that hippocampal and
prefrontal replay events during immobility support planning of upcoming trajectories, and goal representations
impact theta sequences for online maintenance during trajectory execution. Overall, our results will provide novel
insight into fundamental learning and memory mechanisms that are affected in aging and memory disorders
such as Alzheimer’s disease.

Public health relevance
Project Narrative Relevance: Neural interactions between the hippocampus and prefrontal cortex are critical for learning and memory-guided behavior, and dysfunction in these networks is implicated in numerous memory disorders such as dementia and Alzhiemer’s disease, as well as in neuropsychiatric disorders such as autism and schizophrenia. This proposal aims to use novel methods to monitor neural activity and inter-regional coordination during behavior in order to provide an integrated understanding of the role of prominent neurophysiological activity patterns that support our ability to learn, form memories and guide decisions. This project will thus provide crucial insight into neural mechanisms that underlie fundamental cognitive abilities, and contribute to an understanding of the pathophysiology of cognitive dysfunction in numerous disorders.